Thiol/Disulfide Redox Regulation of Heme Oxygenase-2

DESCRIPTION (provided by applicant): Heme oxygenase (HO) catalyzes the conversion of heme to biliverdin, CO, and iron. The two isoforms, HO1 and HO2, share similar physical and kinetic properties but exhibit different physiological roles and organ locations. The structures of the core catalytic domains of HO1 and HO2 are nearly superimposable and the major distinction between these HO isoforms is the occurrence of heme regulatory motifs (HRMs) in HO2 that are lacking in HO1. The HRMs play a regulatory role as a thiol/disulfide redox switch that we have shown to regulate interactions of HO2 with substrate (heme) and with a Ca++- activated high conductance potassium channel (the BK or Slopoke channel). Regulation of K+ flux across the membrane by the BK channel enables the O2 sensing function of the carotid body, which controls respiratory system ventilation in response to changes in the blood oxygen concentration. We recently demonstrated that the BK channel also contains a thiol/disulfide redox switch that regulates binding of heme, which has been shown to control its K+ channel activity. We plan to use spectroscopic, kinetic, genetic, crystallographic, NMR, and electrophysiology methods to determine how these thiol/disulfide redox switches (the HRMs in human HO2 and the CXXC motif in the human BK channel) affect the structure and function of and interactions between these functionally linked proteins. We will determine the redox states of the heme and HRMs in vitro and in vivo under various physiological conditions. We also will perform spectroscopic and electrophysiology measurements to determine the mechanism by which HO2 influences BK channel function.

Public health relevance
Heme oxygenase (HO) is the only mammalian protein known to degrade heme and sits at the nexus of several major redox and metal regulatory systems. Unlike HO1, HO2 contains two Heme Regulatory Motifs (HRMs) that form a thiol/disulfide redox switch, which regulates binding of its substrate, heme. We propose to determine how thiol/disulfide redox switches on HO2 and on a functionally related interacting partner, a heme-regulated potassium channel, regulate their structures and functions.